MTGs in Intestinal Biology and Injury Responses

1 This research proposal investigates the role of Myeloid Translocation Gene on chromosome 16
2 (MTG16) in regulating colon cell identity during homeostasis, regeneration, and dysplasia.
3 MTG16, a transcriptional co-repressor, plays a crucial part in stem cell function and lineage
4 determination in the hematopoietic system. Interestingly, we found that in the colon, MTG16 is
5 highly expressed in secretory precursors and goblet cells, implicating it in colonic goblet-
6 enteroendocrine (EE) cell allocation. Correspondingly, secretory lineages in the Mtg16-/- colon are
7 skewed toward goblet cells at the expense of enteroendocrine cells, positioning MTG16 at the
8 regulatory locus for goblet:EE allocation in the colon. This occurs through MTG16-mediated
9 repression of E protein transcription factors, key players in regenerative processes in numerous
10 tissues. Mtg16-/- mice also have increased sensitivity to colitis and colitis-associated dysplasia,
11 implicating MTG16 as an effector of colonic regeneration processes. However, just how MTG16
12 regulates these processes (i.e. genomic targets and repression complex composition) is largely
13 unknown, offering the potential for new therapeutic targets and interventions in IBD. Using yeast-
14 two-hybrid screens, we identified novel MTG16 interactors, including elongation-associated
15 factors, indicating transcriptional pausing as a new mechanism of MTG16-mediated gene
16 repression. Because MTG16 is expressed in both myeloid and epithelial cells, the observed gut
17 phenotypes could be caused by MTG16 loss in either population. We have observed that wild-
18 type bone marrow transplantation does not rescue Mtg16-/- colon phenotypes, and that these
19 phenotypes also persist in pure epithelial organoids. We hypothesize that MTG16 modulates
20 colonocyte identity during homeostasis, regeneration, and dysplasia by coordinating the
21 restructuring of epithelial transcriptional networks, thus promoting both stability and context-
22 dependent plasticity. Specifically, we predict that MTG16 enables the assembly of multi-protein
23 repression complexes to repress stem and enteroendocrine cell genes, and transcriptional
24 circuits, by modifying chromatin or pausing transcription, thus affecting colonic homeostasis,
25 regeneration, and dysplasia. We will test these hypotheses with three mechanistic, focused aims:
26 1) Define epithelial and/or myeloid MTG16’s contributions to homeostasis, regeneration, and
27 dysplasia; 2) identify context-dependent, colonic cell type-specific MTG16-mediated repression
28 targets; and 3) define colon-relevant MTG16 repression complexes. By unraveling MTG16's
29 molecular function and regulatory networks in colon biology, this project will provide pivotal
30 insights into the pathogenesis of IBD and colon cancer, offering potential therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD) affects more than one million Americans and causes substantial morbidity and suffering, including greater susceptibility to colon cancer. MTG16 is a protein that regulates key differentiation pathways in the colon, affecting damaged colon regeneration and tumor growth in mouse IBD models. We propose to investigate the underlying mechanisms using a combination of biochemical, cellular, and animal experiments with the ultimate goal of improving IBD screening and therapeutics.